Computer Vision-Based Navigation System for High-Precision Orthopedic Trauma Surgery

PROJECT SUMMARY / ABSTRACT Closed or open fracture reduction and internal fixation is the standard surgical approach in treating pelvic fractures, with current clinical practice using fluoroscopic guidance, guidewire insertion, and cannulated screw placement. The challenge in reckoning complex 3D morphology in 2D fluoroscopy presents a major source of uncertainty, trial-and- error, and poor outcomes, with 20-30% rate of suboptimal screw placement and long fluoroscopic runtime (mean fluoro time > 123 s) exposing operating personnel to high levels of radiation exposure. Despite these challenges, mainstream surgical approach has remained largely unchanged for 35 years, and surgical navigation systems (though increasingly common in neurosurgery) present cost and workflow barriers that limit their broad applicability in trauma surgery. We propose a computer vision-based navigation approach that is compatible with routine trauma surgery workflow, offers real-time guidance with accuracy comparable to stereotactic navigation, gives ten-fold reduction in radiation exposure, and works with tools already common in the trauma surgery arsenal. The proposed system uses a miniature stereoscopic camera mounted onboard the surgical drill in combination with 3D-2D registration of fluoroscopic views for direct, real-time registration of the instrument trajectory relative to patient anatomy. Real-time overlay of instrument trajectory in fluoroscopic views and/or CT permits accurate identification of guidewire entry point, orientation, and conformance within bone corridors and will reduce reliance on “fluoro hunting” and trial-and-error guidewire placement. The following aims develop and evaluate the system for application in pelvic trauma surgery, including quantitative assessment of accuracy, workflow, and radiation dose in pre-clinical studies. Aim 1. System for computer vision-based guidance in trauma surgery. The hardware and software components required for vision-based tracking onboard a standard surgical drill will be developed, providing real-time trajectory overlay in fluoroscopy and/or preoperative CT. A fast calibration method will be developed for automatic drill axis calibration. Automatic feature-based registration of the video and fluoroscopic frames enables real-time overlay of instrument trajectory in fluoroscopic views (Fluoro Navigation), and 3D-2D registration between CT and fluoroscopy will enable real-time overlay of the instrument trajectory in CT (CT Navigation). Aim 2: Evaluation in preclinical studies. The vision-based navigation system will be implemented in pre-clinical (cadaver) experiments to evaluate accuracy and workflow. These studies will evaluate the geometric accuracy and workflow factors relating to the number of repeated insertion attempts, procedure time, and radiation dose, evaluating vision-based Fluoro Navigation and CT Navigation in comparison to conventional freehand fluoroscopy guidance. Successful completion of the aims will establish a system suitable for computer vision-based navigation to be translated to clinical studies in future work. Such a system offers a potentially major advance in routine trauma surgery, bringing capabilities comparable to state-of-the-art stereotactic navigation without the cost, complexity, and additional workflow of conventional navigation.

Public health relevance
PROJECT NARRATIVE Even experienced trauma surgeons are challenged in resolving the complex 3D morphology of the pelvis in 2D x-ray fluoroscopy, presenting a major source of uncertainty, a high rate of malpositioned screws, and high levels of radiation exposure to the patient and operating staff. To facilitate high-precision pelvic trauma surgery and reduce intraoperative radiation dose, we propose a computer vision-based navigation approach providing real-time overlay of surgical instrument trajectories in fluoroscopic views and CT, facilitating accurate identification of guidewire entry point, orientation, and conformance within safe bone corridors. The approach offers a major advance compared to conventional navigation by not requiring intraoperative 3D imaging, avoiding time-consuming calibration, and eliminating externally-positioned hardware in the operating room, and the proposed research translates the system from basic development and quantitative testing to preclinical studies evaluating geometric accuracy, workflow, and radiation dose.